Reliability and Validity of Continuous Inter-Limb Stability in Veterans with lower Limb Loss

There is currently no valid or reliable biomechanical variable available to objectively measure the continuous
stability of Veterans with lower limb loss. However, continuous inter-limb stability represents a potential target to
improve whole-body dynamics, as it is an important measure of functional mobility in individuals with lower limb
loss. Determining the reliability and validity of this measure is critical for limb loss care teams since these features
are fundamental to interpretability and assessment of this parameter. Unlike traditional clinical assessments of
stability that focus on the time of task execution, Relative Phase (RP) analysis, which is a novel methodology
that can be used to evaluate continuous stability, uses both space and time within one outcome variable. While
previous literature supports the use of continuous stability for mobility challenged populations, such as individuals
with limb loss, it has yet to be shown reliable and valid for such populations. Therefore, the first aim of this study
is to identify the reliability and validity of continuous inter-limb stability in individuals with transtibial limb loss
(TLL) using RP analysis. For this parameter to be used clinically, it is vital to provide rehabilitation specialists the
ability to assess continuous stability within the clinical setting. To date, this factor of functional mobility has only
been evaluated using 3-dimensional (3-D) motion capture, which is costly and inaccessible to most rehabilitation
clinics. Therefore, the second aim of this study is to identify the strength of the association between wearable
technology (using inertial measurement units) and 3-D motion capture system for evaluation of continuous inter-
limb stability of individuals with TLL. The central hypothesis is that continuous stability evaluated using RP
analysis will be a reliable and valid measure of functional mobility for Veterans with TLL and that data captured
via wearable technology will be strongly associated with 3-D analysis. Twenty Veterans with TLL will be recruited
and enrolled via the Prosthetic or Physical Medicine Departments at Veterans Affairs New York Harbor
Healthcare System, where all data collection will occur. To measure test re-test reliability, participants will
undergo 3 sessions of 3-D gait analysis while walking at a moderate speed (1.3m/s) until 15 walking cycles are
captured, with 1 day between sessions. RP analysis will be used to identify the continuous inter-limb stability of
gait patterns. Participants will be fit with wearable technology and data will be collected concurrently. To measure
convergent validity, participants will perform functional outcome measures including the Timed Up and Go test,
6 Minute Walk Test, Hill and Stair Assessment Indexes, and Amputee Mobility Predictor. Data from 40
participants are required to appropriately power the analysis of convergent validity. To achieve this power, data
from 20 participants collected during a previously funded Department of Defense study will be leveraged and
added to the data of the 20 participants collected during the proposed study. This is possible due to identical
data collection techniques in both studies. To assess the level of agreement between the data obtained from the
3 sessions, Intraclass Correlation Coefficients will be calculated for each variable, in addition to Cohen’s kappa
statistics and Pearson correlation coefficients. To assess convergent validity, Pearson and Spearman rank
correlation coefficients will quantify the strength and direction of the relationships between the outcome
measures and continuous stability. Substantiating the use of continuous stability in Veterans with TLL will afford
healthcare providers information necessary to accurately detect and appropriately address stability deficiencies,
which is critical since superior stability is linked to increased physical activity leading to an enhanced overall
quality of life of Veterans with limb loss. Verifying the reliability and validity of this parameter will lead to its
confident application for future studies focused on effectiveness, optimization, and rehabilitation.

Public health relevance
To date, there is no valid and reliable measure of continuous inter-limb stability available to healthcare teams treating people with lower limb loss. Determining these characteristics of this parameter for this population is important because superior stability has been linked to increased physical activity and strength in similar populations, making it a potential vital contributor to mobility improvement of Veterans with limb loss. It is also crucial that healthcare providers can easily measure continuous stability in the clinic instead of relying on expensive laboratory equipment. The overall goals of this study are to determine the reliability and validity of continuous inter-limb stability of Veterans with lower limb loss and determine if this parameter can be captured using accessible wearable technology. Consequently, clinicians can improve continuous stability through proper rehabilitation to positively impact the functional mobility and overall quality of life of Veterans with lower limb loss.